Microscopy and Cell Analysis Shared Resource

MICROSCOPY AND CELL ANALYSIS SHARED RESOURCE: ABSTRACT
The Microscopy and Cell Analysis Shared Resource (MCASR) offers state-of-the-art fluorescence-activated cell
sorting (FACS) cytometry, optical and electron microscopy techniques, and advanced instrumentation, training,
cyberinfrastructure, and expertise for cancer research. The MCASR facilitates the study and analysis of
molecular, cellular, and tissue dynamics and three-dimensional architecture crucial for understanding cancer
causation and treatment to meet its three Specific Aims:
Aim 1: Provide training, access, support, and expertise enabling Mayo Clinic Comprehensive Cancer Center
(MCCCC) members to use advanced imaging and FACS cytometry techniques in their research.
Aim 2: Advise and assist MCCCC members in the design, planning, and execution of experimental studies
using high-end imaging, cell sorting, and data analysis.
Aim 3: Provide MCCCC members state-of-the-art microscopy and cell sorting instrumentation, expertise, and
cyberinfrastructure to efficiently handle data storage, transfer, management, and analysis.
The MCASR has extensive experience and is well equipped and staffed for advanced FACS and analysis,
metabolic studies using the Seahorse Bioscience XF extracellular flux analyzer, and optical and electron
microscopy imaging techniques, including super-resolution microscopy, multiphoton microscopy, confocal
microscopy, total internal reflection fluorescence (TIRF), fluorescence resonance energy transfer (FRET),
fluorescence recovery after photobleaching (FRAP), standard transmission and scanning electron microscopy,
and serial block-face scanning electron microscopy to provide three-dimensional images.
About 40% of MCASR users are MCCCC members, who represent about 14% of overall revenue from charges.
The MCASR has supported 53 publications by MCCCC members in the current funding period.
Member Utilization 2019-2023: 182 Total (8 CPCS, 9 REDI, 48 CGSM, 45 CII, 39 NTTM, 33 ACTS)
Publication by Members: 53, 24 with Impact Factor >10